Pilot study for low-cost, rapid, and accessible infectious disease diagnostics via alpha particle detection

The following contains proprietary/privileged information that Travis Schlappi and Kevin Hickerson request not be
released to persons outside the government, except for purposes of review and evaluation.
Summary:
Diagnosis of infectious disease is less effective when the diagnostic test does not meet one or more of the
necessary standards of affordability, accessibility, and accuracy. The shortcomings of current diagnostic
methods have been apparent in the COVID-19 pandemic, where some tests are accurate, but not affordable or
accessible (e.g. RT-PCR tests that detect COVID RNA in a centralized lab), while other tests have become more
accessible and affordable, but have low accuracy (e.g. rapid antigen tests). The high false negative rate of rapid
antigen tests precludes their ability to limit disease transmission as asymptomatic carriers that test negative
continue infecting others; therefore, RT-PCR or other nucleic acid (NA) tests remain the preferred testing
method. This tradeoff of high accuracy with high cost, high complexity, and slow turnaround time, or low accuracy
with low cost, low complexity, and fast turnaround time is an unsolved problem in medical diagnostics. The critical
barrier to making progress is that the bacteria, viruses, NAs, or proteins of interest exist in the respiratory, blood,
stool, or urine sample in too low of a concentration to be directly detected. To achieve sufficient sensitivity,
current methods therefore amplify the pathogenic organism or amplify a target biomolecule coming from the
pathogen. Even with recent advances, these amplification methods still require many steps and costly
instruments to purify the target molecule from the sample and perform amplification. The goal of the proposed
project is to do a pilot study for developing a new diagnostic technology that does not require target amplification,
but instead detects radiologically labeled biomolecules with high sensitivity, low cost, and widespread
accessibility. The proposed principle is similar to a sandwich immunoassay commonly found on lateral flow strips,
such as at-home pregnancy tests. In Aim 1, nanoparticles of naturally abundant elements that have functionally
identical radioisotopes will be formulated and characterized. The results from these experiments will inform which
radioisotope is well-suited to be used in an integrated device. In Aim 2, a prototype will be developed for a
radioactive particle detector from inexpensive, commercially available electronics, such as a CMOS sensor from
a smartphone. The final detection device will be significantly simpler and cheaper than currently available tests
because the multiple fluid handling and temperature control steps typically required for target purification and/or
enzymatic amplification are avoided. If this pilot study proves successful, future work will develop an in vitro
diagnostic device to detect infectious disease that satisfies all ASSURED criteria (affordable, sensitive, specific,
user-friendly, rapid, equipment-free, deliverable). Clinical practice, disease management, pandemic
preparedness, and healthcare of citizens around the globe would be transformed with rapid (<5 min), affordable
(<$5), sensitive, and accessible tests for infectious diseases.

Public health relevance
The following contains proprietary/privileged information that Travis Schlappi and Kevin Hickerson request not be released to persons outside the government, except for purposes of review and evaluation. Narrative: This proposed research would enable healthcare systems and people in all settings to diagnose infectious diseases rapidly, accurately, and inexpensively. This ability would prevent people from spreading disease unknowingly and improve treatment outcomes due to an accurate knowledge of what is causing a patient's symptoms. Clinical practice, disease management, pandemic preparedness, and healthcare of citizens around the globe would be transformed with rapid (<5 min), affordable (<$5), sensitive, and accessible tests for infectious diseases.